Development of neutral sphingomyelinase 2 (nSMase2) inhibitors for the treatment of Alzheimer's disease

PROJECT SUMMARY
Neutral sphingomyelinase 2 (nSMase2 encoded by SMPD3 gene) is a membrane associated enzyme that
catalyzes the hydrolysis of sphingomyelin (SM) into phosphorylcholine and ceramide. Formation of ceramide-
enriched areas by the action of nSMase2 is known to facilitate generation of extracellular vesicles, which
participate in intercellular communication in both physiological and pathological processes through
encapsulation and transfer of diverse types of substances including tau protein. Interestingly, post-mortem brains
from AD patients exhibit abnormal increases in ceramide. Inhibition of nSMase2 has therefore become an
attractive therapeutic strategy to treat AD by inhibiting EV biogenesis to slow the spread of pathogenic cargo.
The main objective of this project is to conduct structural optimization using (R)-(1-(3-(3,4-dimethoxyphenyl)-2,6-
dimethylimidazo[1,2-b]pyridazin-8-yl)pyrrolidin-3-yl)-carbamate (PDDC), a prototype nSMase2 inhibitor, as a
molecular template with the ultimate goal of identifying development candidates with balanced overall
pharmacological profiles required for clinical translation. By assembling a multidisciplinary team of investigators
with complementary expertise, we are poised to seize this opportunity by executing the following specific aims;
(Aim 1) Conduct structure-activity relationship (SAR) studies on nSMase2 inhibitors containing a core scaffold
different from that of PDDC; (Aim 2) Characterize the ADME (absorption, distribution, metabolism and excretion)
and in vitro selectivity/toxicity profile of potent nSMase2 inhibitors from Aim 1. Identify optimal dosing for efficacy
studies in Aim 3; (Aim 3) Evaluate selected nSMase2 inhibitors from Aim 2 for efficacy and tolerability in an AAV
tau propagation model and a PS19 transgenic model of AD.

Public health relevance
Project Narrative An estimated 6.5 million Americans age 65 and older are living with Alzheimer's disease (AD) today and this number could grow to 13.8 million by 2060 barring the development of medical breakthroughs to prevent, slow or cure AD. Current treatments for AD are symptomatic, with modest effect sizes and limited impact on longer- term disease outcomes. The goal of the proposal is to develop orally available and brain-penetrant neutral sphingomyelinase 2 (nSMase2) inhibitors mechanistically distinct from other therapeutic approaches, aiming at bringing a novel treatment option that can potentially delay or slow the progression of AD.